Multi-Resolution Docking Methods for Electron Microscopy

Summary
In the past decade, we have witnessed revolutionary progress in the attainable resolution of macromolecular
assemblies via cryo-electron microscopy (cryo-EM) and in the development of deep learning algorithms (such
as AlphaFold) that reliably predict atomic structures that can be fitted to cryo-EM maps. Whereas single-
particle cryo-EM today is capable of directly solving the atomic structures of biomolecular assemblies in
isolation, cryo-electron tomography (cryo-ET) is widely used in unstained frozen-hydrated samples to capture
the 3D organization of supramolecular complexes in their native (organelle, cell, or tissue) environments. The
increasing availability of high-quality maps and corresponding atomic models enables the validation of
computational strategies, yielding rigorous and reproducible modeling technologies for the future. In this
proposal, we have identified research areas for the next five years and beyond, leveraging our computational
modeling experience (historically rooted in pre-revolution multi-scale approaches) to offer the biggest value to
today’s post-revolution EM community. Our vision is to combine the converging advancements in cryo-EM,
cryo-ET, structure prediction, and rigorous validation of modeling methods into a comprehensive research
strategy. We will quantitatively measure the fitness of an atomic model in local density regions and
characterize the fitness of maps with reliable reference structures. This will lead to new breakthroughs in the
flexible fitting and refinement of AlphaFold2 models as well as secondary structure prediction for medium-
resolution maps, which have been our key research areas in recent years. Medium- to low-resolution maps are
still widely used in EM and can be of significant biological importance. This is particularly true in the case of
cryo-ET maps, which are harder to read than single-particle cryo-EM maps because they often exhibit
considerable noise, anisotropic resolution, and anisotropic density variations due to the low dose requirements
and the missing wedge in the Fourier space. As automated segmentation algorithms in cryo-ET continue to
improve, validation of these approaches has become more incumbent. Having a known ground truth on which
to base predictions is crucial to reliably testing predicted structures and modeling approaches. We propose a
software tool for the realistic simulation of “phantom” cryo-ET maps. We describe current and future
applications in the validation of cytoskeletal filament tracing methods. The collaborative efforts supported by
this grant will include the refinement of cytoskeletal actin filaments, molecular motors, bacterial chemoreceptor
arrays, and hair cell stereocilia. The algorithmic and methodological developments will be distributed freely
through the established Internet-based mechanisms used by the Situs and Sculptor packages and as plugins
for the popular UCSF Chimera graphics program.

Public health relevance
Project Narrative This project will help biological electron microscopists bridge a broad range of resolution levels, from the atomic to the living organism. The results of our research in electron microscopy and tomography will be new computer codes for modeling the structures of macromolecular assemblies. As the basic functional units of biological cells, macromolecular assemblies furnish targets for drug design because deficiencies in the assembly architecture are frequently linked to health problems.